Validation of the Recovery of B. Anthracis Spores from NHP

This agreement will support the evaluation of anthrax spore persistence in the tissues of infected Rhesus macaques, to test the long-standing assumption that a 60 day prophylactic antibiotic regimen is required to treat anthrax.